Immune and neuroendocrine mediators of sex-differences in pain following traumatic burn injury

PROJECT SUMMARY/ABSTRACT
Traumatic burn injuries generate excruciating pain resulting from tissue and nerve damage and the
accompanying exaggeration of inflammation. Necessary wound care procedures such as debridement, burn
excision, grafting, and mobilization only add to this pain. For these reasons, pain from traumatic burn injury is
notoriously difficult to manage; hence current reports suggest that burn-related pain is currently undertreated.
Traumatic injuries have a dramatic increase in pain sensitivity (hyperalgesia) and accelerated development of
tolerance to opioid analgesics compared with non-traumatic injuries. Unfortunately, the mechanisms driving
increased sensitivity and tolerance following trauma are unclear. Furthermore, over half of all burn survivors
develop chronic pain, making the transition from acute to chronic pain a significant concern following burn injury.
Research has primarily focused on the innate immune response to injury as a leading candidate; however, the
recent inclusion of female subjects has uncovered sex-specific differences in immune-modulated pain sensitivity.
These findings have led to reconsideration of the influence of sex on pain processing and whether the body of
male-only research is truly applicable. It is well known that females are more likely to report more severe pain
and to experience chronic pain following such injuries; however, the mechanisms behind these sex-specific
differences are currently unknown. Additionally, stress-induced adaptations in the neuroendocrine system are
believed to play an essential role in the pathogenesis of acute and chronic pain outcomes. Dysregulation of the
hypothalamic-pituitary-adrenal and sympathoadrenal axes following traumatic injury has been shown to reduce
the activity of descending pathways that modulate endogenous pain inhibition and opioid analgesia. We
hypothesize that the immune response involved in the pathogenesis of pain following traumatic burn injury is
regulated in a sex-specific manner through involvement of the neuroendocrine system. Exploiting these sex-
specific differences may be key to understanding how to treat pain generated from traumatic burn injuries. Sex-
specific genes, hormones, and signaling mechanisms may shed light on novel targets that have been previously
overlooked, giving great hope for future sex-specific interventions. Accordingly, the proposed research program
will address this critical gap in our understanding by systematically investigating the role of sex-specific immune
reactivity and neuroendocrine responses in an animal model of full-thickness thermal burn injury. This program
of research will lead us closer to understanding mechanisms that make pain from traumatic burn injuries so
challenging to treat and identify sex-related drivers behind them. Our goal over the duration of this award is to
identify sex-specific mechanisms underlying the accelerated development of tolerance and hyperalgesia and to
provide insight to potential targets for sex-specific interventions to treat acute pain and prevent the transition to
chronic pain. Conduct of these studies will build a robust program of research positioned to investigate any
promising targets we may uncover.

Public health relevance
PROJECT NARRATIVE Pain from traumatic burn injuries is likely the most severe form of pain imaginable, yet reports suggest that burn- related pain is currently undertreated. Women report more severe pain and are more likely than men to experience chronic pain following burn injuries. In this proposed program of research, we will investigate the immune and neuroendocrine mechanisms behind these sex differences in pain following traumatic burn injuries.